Linking Motor Cortex Activity and Movement in the Mouse Orofacial System

Information flow through neural circuits is dynamic. The set of brain areas that are engaged in computation are
ever changing according to behavioral demands. How circuits in the brain are functionally coupled and
uncoupled on behavioral time scales so that information can be relayed to the appropriate place at the
appropriate time remains a major outstanding question in systems neuroscience. This question is of particular
relevance in the motor system. The production of movements is one of the most fundamental functions of the
brain, and in mammals, flexible movements depend on the motor cortex. Neural activity in the motor is cortex
complex, made up of control signals that drive movements in addition to activity related to motor planning,
learning, and other cognitive processes. This wide array of signals is multiplexed within the same circuit and,
often, within the same cells. How does the brain regulate which activity patterns are communicated to the
periphery to drive movements and which are confined to local circuits for local cortical computation? An
influential hypothesis proposed to explain why only some activity patterns generate movements – the null
space model – provides a biologically plausible computational strategy for segregating cognitive signals from
those that are transmitted to the periphery to produce movement. The null space model suggests that
cognitive signals are restricted to patterns whose impact on downstream motor areas effectively cancel out –
they are ‘output-null.’ Preliminary evidence suggests that activity patterns in the primate motor cortex may be
consistent with the null space model, but thus far it has been challenging to establish a causal link between
these neural activity patterns and behavior.
In this proposal, we examine the flow of neural signals from the motor cortex to the motor neurons that control
the musculature to determine whether the null space model accurately predicts which neural signals have a
causal role in generating movements. Powerful, emerging methods for multi-regional physiology allow us to
examine neural activity at each processing stage along this pathway, an essential requirement for
understanding how cortical activity patterns are transformed into movements. Cell-type specific optogenetic
perturbations allow us to disambiguate the neural signals that drive movements from those that are simply a
consequence and will help to establish a causal relationship between neural activity and movements.
Understanding how neural activity relates to behavior will ultimately help us better interpret the deficits
expressed in movement disorders and motivate improved brain-machine interfaces and biomimetic control
strategies for use in the next generation of artificial systems.

Public health relevance
In mammals, the motor cortex plays a key role in the control of voluntary movements, but how neural activity in the motor cortex is related to movement remains poorly understood. In this project, we leverage powerful experimental methods or recording and perturbing neural activity across multiregional circuits in the brain to determine how neural activity is transformed at each processing stage between the motor cortex and the musculature. A synthesis of these data and computational modeling results will allow us to evaluate the validity of a leading model of movement control by the motor cortex to help us link neural activity to behavior.